Dendritic cell lysosomes in immune checkpoint inhibitor-associated myocarditis

PROJECT SUMMARY/ABSTRACT
This project has two overarching goals: (1) to investigate the role of dendritic cell (DC) lysosome activity in
immune checkpoint inhibitor (ICI)-associated myocarditis, and (2) to serve as a platform for further research and
career training of the PI, Dr. Kenji Rowel Lim, to transition to independence. Although tremendously successful,
ICIs in cancer therapy induce several immune-related adverse effects. ICI myocarditis is a highly fatal disease
of inflammation-induced cardiac injury, with its incidence expected to rise due to improved diagnosis and in-
creased ICI use in the clinic. Effective treatments are unavailable and urgently needed. Research has tradition-
ally focused on how unrestrained autoreactive T cell activation from loss of immune checkpoint inhibition fuels
ICI myocarditis. Preliminary work by the PI suggests that DCs, which take up and present antigens to T cells for
activation, are also affected under these conditions, highlighting a previously unexplored layer of complexity in
this disease. In particular, the PI found that DC lysosomes had reduced activity in the absence of immune check-
point inhibition. Based on these data, it is hypothesized that reduced DC lysosomal activity in ICI myocarditis
leads to reduced degradation of internalized antigens, better preserving epitopes, enhancing presentation, and
increasing T cell activation. This hypothesis will be tested by characterizing differences in lysosomal activity
between wild-type DCs and DCs deficient in the immune checkpoint receptor PD-1 (PD-1 KO), and establishing
a connection between PD-1 signaling and lysosomal activity (Aim 1); determining if reducing lysosomal activity
in DCs provokes myocarditis in the setting of cardiac injury (Aim 2); and determining if enhancing lysosomal
activity in PD-1 KO DCs prevents ICI myocarditis (Aim 3). This project will advance understanding of ICI myo-
carditis biology and uncover potential therapies for this disease. The PI has extensive research experience in
molecular biology, genetics, and cardiac immunology, from previous Ph.D. training in Canada and postdoctoral
training with Drs. Abhinav Diwan and Douglas Mann. The PI seeks to acquire additional training via a mentored
approach to complete the proposed work and transition to independence. In their career development plan, the
PI aims to: (1) acquire further scientific training in immunology and lysosomal biology to enable the pursuit of
innovative cardiac immunology research, (2) acquire training in leadership, mentoring, lab management, and
grant writing to become an effective principal investigator, and (3) actively prepare to secure a faculty position at
a top-tier research institution. In addition to their primary mentor (Dr. Diwan) and co-mentor (Dr. Mann), the PI
will be mentored by a team of leading experts in cardiac immunology (Dr. Sumanth Prabhu, Dr. Pilar Alcaide),
and lysosomal biology (Dr. Marco Sardiello), who will also advise on career development. With the exceptionally
supportive research environment at Washington University in St. Louis, this training experience will enable the
PI’s successful transition to becoming an independent investigator, advancing knowledge on how the immune
system shapes the heart, and using this understanding to develop novel, effective therapies for cardiac disease.

Public health relevance
PROJECT NARRATIVE A hallmark of the immune system is its ability to discriminate self from non-self, a mechanism that is dysregulated in forms of cardiac disease such as immune checkpoint inhibitor-associated myocarditis, which is highly fatal. The proposed work will investigate the contributions of dendritic cell lysosome-mediated antigen processing to the expansion of cardiac autoreactive T cells in this condition. This study will yield powerful insights into the subcellular mechanisms of autoimmunity in immune checkpoint inhibitor-associated myocarditis, and into the development of therapeutic approaches for this condition that are based on the modulation of lysosomal activity in dendritic cells.